Imaging Neonatal Hypoxic Ischemic Injury

Abstract
Hypoxic ischemic (HI) insult damages both white matter and grey matter in infants and causes significant
mortality and morbidity. To investigate the pathological mechanisms of neonatal HI injury and find satisfactory
treatments, animal models of neonatal HI injury have been established and widely used. In this project, novel in
vivo magnetic resonance imaging techniques that target tissue microstructure and water exchange between
intra- and extra-cellular spaces will be developed to examine the progression of HI injury and the effects of
therapeutic hypothermia in a neonatal mouse model.
In aim 1, we will develop diffusion MRI (dMRI) based techniques to measure microstructural changes and
water exchange and validated the techniques using histology. We will use these techniques to characterize the
extent and severity of cell death and to predict tissue survival in edema regions. In aim 2, we will further validate
the dMRI techniques developed in aim 1 using maps of metabolites and lipids generated using mass
spectrometry imaging. In aim 3, the techniques developed in the first two aims will be applied to characterize HI
injury in mice treated with hypothermia to study its effects and elucidate its neuroprotective mechanisms.
We expect the project to extend our knowledge on the relationships between HI pathology and diagnostic
markers in this mouse model and shed light on the mechanisms of HI injury and therapeutic hypothermia. This
information and techniques developed in this project will be useful to design effective strategies for intervention
and to monitor treatment response in studies using this or similar models.

Public health relevance
Narrative: Neonatal hypoxic ischemic (HI) injury causes significant mortality and morbidity, and the only effective treatment is hypothermia. We will develop in vivo magnetic resonance imaging techniques, together with other imaging modalities, to assess tissue injury and survival after HI using a well-established mouse model of neonatal HI injury. The proposed techniques can potentially shed light on the mechanisms of HI injury and therapeutic hypothermia.